PROJECT 1 – STRUCTURAL BIOLOGY OF DNA DEAMINASES IN CANCER

PROJECT 1 – STRUCTURAL BIOLOGY OF DNA DEAMINASES IN CANCER
ABSTRACT
The human APOBEC3 (A3) family of deaminases catalyze the conversion of cytosine to uracil in single-
stranded DNA to elicit mutations and genome instability, which in turn promote tumor evolution and the
development of therapy resistance and metastatic disease. However, despite the large overall impact of A3-
mediated mutagenesis in human cancer and the likely benefits of inhibiting A3-mediated mutagenesis, targeting
the A3 family of deaminases for catalytic inhibition and/or selective degradation has remained unfulfilled,
challenging us to test the overarching hypothesis that blocking A3 mutagenesis will slow tumor evolution. In
addition, several important questions regarding the mechanisms of A3-mediated DNA deamination remain
unanswered. The goal of Project 1 – Structural Biology of DNA Deaminases in Cancer is to use the
techniques of structural biology to reveal how small-molecule, oligonucleotide, and macromolecular antagonists
interact with the A3 proteins to address specific mechanistic hypotheses about A3-mediated DNA deamination
and its inhibition. We focus on APOBEC3A (A3A) and APOBEC3B (A3B), as they are the major drivers of tumor
evolution. A3A/B antagonists include validated hit compounds from a high-throughput small-molecule inhibitor
screen conducted by Core B, fragment binders identified in preliminary studies by this Project and Project 2,
oligonucleotide-based inhibitors developed by Project 2, camelid-derived nanobodies, and natural A3 inhibitors
from viruses. Not only will the structural information obtained in our studies be instrumental in the future
development of targeted therapies, but these reagents will be invaluable in the specific detection of A3 proteins
in cells and tissues as well as facilitating structural, biochemical, and cell biological studies to gain further insights
into how A3 enzymes function inside normal and tumor cells. We will continue to work closely with all
Projects/Cores to leverage the discoveries and novel reagents we develop to test both our overarching and
specific, mechanistic hypotheses and, ultimately, help position the field for novel cancer treatments that include
evolution-blocking agents.

Public health relevance
PROJECT 1 – STRUCTURAL BIOLOGY OF DNA DEAMINASES IN CANCER NARRATIVE APOBEC3A and APOBEC3B are DNA-mutating enzymes that are now widely recognized as major sources of genomic mutations in cancer. The overarching hypothesis of this Program is that inhibition of these APOBEC3 proteins will serve to complement cancer therapy by suppressing mutations that lead to drug resistance and metastasis. Project 1 will characterize various types of APOBEC3A/B antagonists, including small molecules, oligonucleotide-based inhibitors, camelid-derived nanobodies, and natural APOBEC3 inhibitors from viruses, to help test this hypothesis and position the field for novel cancer treatments that include evolution-blocking agents.